CLINICAL DATA CENTER SERVICES FOR THE EARLY ONSET MALIGNANCIES INITIATIVE

This Task Order provides support to the Early Onset Malignancies Initiative (EOMI). The EOMI is a collaborative initiative between CCG and the Division of Cancer Prevention’s NCI Community Oncology Research Program (NCORP) investigating why certain racial and ethnic populations are at increased risk of developing cancer at an early age, The EOMI will focus on six cancer types that in certain minority populations develop at an earlier age, occur in higher rates, and are typically more aggressive. CDC Support for EOMI includes the following: Human Subjects Compliance, Clinical Data Procurement, Clinical Data Validation, Data Distribution, Informatics, and provides support for external Expert Pathology Committee (EPC).